RBC Effects on Neutrophil Activation and Phenotypes in Sickle Cell Disease

Project Summary/Abstract
Increasing evidence suggests that activated neutrophils play a critical role in promoting vaso-occlusion and
morbidity in sickle cell disease (SCD). Multiple factors are thought to contribute to neutrophil activation in SCD,
including products of red cell (RBC) hemolysis and cellular interactions between neutrophils and the endothelium
or platelets. Once neutrophils are activated, stimulus-dependent effects on neutrophil phenotype and functional
capacity have been reported, resulting in dysfunctional neutrophils which propagate inflammation. Unlike prior
studies in SCD which largely suggest that neutrophil activation occurs via indirect mediators, our preliminary
data support the hypothesis that sickle RBCs (SS RBCs) directly activate neutrophils, resulting in enhanced
adhesiveness and increased degranulation responses. We show that these 2 effector functions are further
enhanced when SS RBC phosphatidylserine (PS) exposure is increased and when SS RBC adhesion receptors
are activated. Furthermore, our preliminary studies show that in steady-state, exchange transfusion reduces
neutrophil activation. Based on the preliminary data presented in this application, we will test the hypothesis that
intact SS RBCs induce a specific neutrophil activation profile which recapitulates neutrophil dysfunction in SCD.
We also hypothesize that therapies that reduce the RBC characteristics enabling this effect might both reduce
neutrophil activation and decrease the frequency and severity of vaso-occlusive events. In Aims 1 and 2, we will
delineate upstream characteristics of RBCs contributing to neutrophil activation as well as downstream
consequences of SS RBC-induced neutrophil interaction in vitro. In Aim 1, we will establish the effect of SS
RBCs on neutrophil phenotype, function, and gene expression. In Aim 2, we will establish the requirements
needed for SS RBCs to activate neutrophils by examining physical requirements such as concentration
thresholds and need for contact. We will also establish the role of PS exposure and the known activatable RBC
membrane adhesion receptors (BCAM/Lu, ICAM4, CD47, and CD44) on neutrophil activation. In Aim 3, we will
determine if the SS RBC-neutrophil interactions and measures of neutrophil activation we have described in vitro
reflect those seen in patients during acute chest syndrome (ACS). In addition, we will determine the effect of
transfusion, which we have shown affects neutrophil activation in steady-state, on in vivo neutrophil activation
during acute illness. Together, these studies build on our novel observation that SS RBCs are able to directly
induce neutrophil activation. The work outlined in this proposal will systematically define the characteristics of
SS RBCs which cause neutrophil activation and the functional/phenotypic/transcriptional changes seen in
neutrophils after activation by SS RBCs. These results will potentially identify new therapeutic targets and will
provide significant biologic insight into the role of neutrophil-RBC interactions in SCD.

Public health relevance
Project Narrative We have found that sickle red blood cells can directly activate neutrophils, resulting in abnormal neutrophil function. In this application, we will define the properties of sickle red blood cells which cause neutrophils to become activated, and we will determine the consequences which occur as a result of neutrophil activation. These findings may provide new explanations for how complications occur in sickle cell disease and may identify new strategies to prevent such complications.